From protein structures to effective drugs via machine learning and molecular simulation

Project Summary
Recent years have seen dramatic breakthroughs in methods for determining structures of proteins
and other drug targets experimentally (e.g., cryo-EM) and predicting them computationally (e.g.,
AlphaFold). These advances tremendously increase the potential of structure-based drug
discovery, but going from an accurate target structure to an effective drug remains a difficult
problem. To do so, once must design molecules that bind tightly and selectively to the target,
have appropriate (drug-like) physiochemical properties, and exert a desired effect on the target’s
function. This project will make advances in several areas critical to enabling the efficient
structure-based design of effective, safe drugs:
1. Creation of machine learning methods to accurately predict a chemical compound’s
binding affinity, drawing simultaneously on the target’s structure and experimentally
determined affinities of other compounds that do or do not bind the target.
2. Development of machine learning methods to design drug-like ligands that bind tightly and
selectively, exploiting both generative artificial intelligence and iteration between
computation and experiments.
3. Determination of the mechanisms by which drugs can selectively stimulate or selectively
block arrestin signaling at diverse GPCRs, achieving desired therapeutic effects without
dangerous side effects.
This research builds on recent achievements of the Principal Investigator, Ron Dror, in two areas:
(a) machine learning methods for structural biology, and (b) elucidation of the structural basis of
GPCR signaling. It continues his record of collaborating with experimentalists to do innovative
computational work with a strong impact on experimental biochemistry, structural biology,
pharmacology, and drug design.

Public health relevance
Project Narrative The proposed research focuses on development of computational methods to tackle long- standing problems critical to the efficient design of safe, effective drugs: given the folded structure of a protein, how does one design chemical compounds that bind to that protein tightly and specifically, and how does one design compounds that have the desired effect on the protein’s function? This research will enable the development of novel therapeutics to reduce illness and disability, supporting the NIH’s mission.